ANTITUMOR EFFECTS OF AG-337 GIVEN BY CONTINUOUS INFUSION FOR FIVE DAYS

To confirm phase ii starting dose for 5-day infusion for ag-337 and to describe toxicities associated with a 120-hr continuous infusion of ag-337 at the recommended phase ii dose. To assess antitumor effects induced by ag-337 during phase I escalation and to study pharmacokinetics of ag-337 during treatment courses.